Summer Institute in Statistics and Modeling in Infectious Diseases

ABSTRACT
The overall goal of the annual Summer Institute in Statistics and Modeling in Infectious
Diseases (SISMID) at the University of Washington is to educate the next generation of
researchers in a broad range of state-of-the-art quantitative methods for infectious
disease research. Courses for skill development: SISMID is a collection of 16 2.5-day
modules offered over 2.5 weeks in July on a variety of topics relevant to research
education in statistics, modeling and computational methods applied to infectious
diseases. Most participants take on average three modules per year. SISMID has been
held each summer since 2009. This proposal requests funds for 2020-2024. The 2020
SISMID proposes to offer the following: 1. Probability and Statistical Inference; 2.
Mathematical Models of Infectious Diseases; 3. Introduction to R; 4. Causal Inference; 5.
Evolutionary Dynamics and Molecular Epidemiology of Viruses; 6. Stochastic Epidemic
Models with Inference; 7. Markov chain Monte Carlo I; 8. Microbiome Data Analysis; 9.
Pathogen Evolution, Selection, and Immunity; 10. Simulation-based Inference for
Epidemiologic Dynamics; 11. Statistics and Modeling with Novel Data Streams; 12.
Infectious Diseases, Immunology, Within Host Models; 13. Markov chain Monte Carlo II
for Infectious Diseases; 14. Spatial Statistics in Epidemiology and Public Health; 15.
Contact Network Epidemiology: 16. Reconstructing Transmission with Genomic Data.
The instructors are drawn from the University of Washington and other academic
institutions in the USA and Europe, and industry. Instructor mentors will be assigned to
recipients of support through this grant and put into email contact before SISMID. They
will meet together during SISMID. Research experiences will include teams working on
ongoing projects and using innovative methods for reproducible research. This NIAID
Research Education Program (R25) will allow us to provide graduate students and
postdoctoral fellows approximately 350 modules per year without charge and 100 partial
travel awards.

Public health relevance
Public Health Relevance Statement Statistical and mathematical methods for the study of infectious diseases and for discovery and evaluation of interventions have become increasingly important. The Summer Institute in Statistics and Modeling in Infectious Diseases (SISMID) provides necessary and innovative training in statistical and mathematical modeling to students, postdoctoral fellows, and professionals. This research education program enables them to formulate research questions, analyze data, design studies, and model dynamics and evolution of infectious diseases including emerging infectious diseases relevant to important public health and biomedical research questions.